The effect of laminar and disturbed flow on endothelial glucose metabolism

Endothelial metabolism has recently re-emerged as a powerful tool to regulate vascular function. However,
studies have focused entirely on glycolytic flux regulation via PFKFB3 and its effects in angiogenesis. Little is
known about how endothelial cell metabolism impacts macrovascular endothelial function in health and disease.
Endothelial cells are constantly exposed to shear stress from the flowing blood. Endothelial cells in steady
laminar flow express a quiescent phenotype, maintaining vascular homeostasis through control of proliferation,
permeability, inflammation, and vascular tone. Endothelial cells in oscillating disturbed flow express an athero-
prone phenotype with elevated proliferation, permeability, and inflammatory adhesion molecule expression as
well as impaired NO production (defined as endothelial dysfunction). Disturbed flow regions are linked to
subsequent pathological vascular remodeling including atherosclerotic plaque development.
Recently, endothelial cells in steady laminar reduced glycolysis partially via KLF2-mediated repression of
PFKFB3. However, concurrent KLF2 and PFKFB3 overexpression did not fully restore glycolytic rate,
suggesting that other metabolic mediators are involved. Our data show that endothelial cells in steady
laminar flow reduce glycolytic flux at shorter times with no change in PFKFB3 expression, and that endothelial
cells in oscillating disturbed flow do not decrease glycolytic flux. Our data also show that flow regulates the
hexosamine biosynthetic pathway, a side branch of glycolysis which controls protein O-GlcNAcylation, and acetyl
CoA, which is critical to lipid synthesis and histone acetylation. We are only beginning to discover
mechanisms by which shear stress affects endothelial glucose metabolism and downstream pathways.
Our long term goal is to modulate glucose metabolism to reduce endothelial dysfunction in disturbed flow.
The goal of this project is to understand how steady laminar and oscillating disturbed flow differentially affect
macrovascular endothelial glycolytic flux, the HBP, and acetyl CoA metabolism. We hypothesize that mean shear
stress greater than 12 dynes/cm2 reduces glycolytic flux, eNOS O-GlcNAcylation, and acetyl CoA to promote an
athero-protective endothelial phenotype. To test this hypothesis, we will (1) determine how steady laminar and
oscillating disturbed flow regulate endothelial glycolytic flux; (2) determine how steady laminar and
oscillating disturbed flow affect eNOS O-GlcNAcylation; and (3) determine how altered acetyl CoA in
flow impacts lipid synthesis and histone acetylation
Since atherosclerosis is a disease of altered metabolism, we will use a combination of in vitro and ex vivo
experiments to discover mechanisms underlying changes in glucose metabolism with flow. Our team is uniquely
prepared to pursue this research, with expertise in endothelial hemodynamics, metabolic mass spectrometry, O-
GlcNAcylation, and ex vivo vessel analysis. These data will transform the field by creating a new research area
at the intersection of hemodynamics and metabolomics.

Public health relevance
Atherosclerosis occurs at vessel branches, where blood flow is abnormal. In this project, we will study how abnormal blood flow affects the way in which vascular cells metabolize glucose. This research will lead to new understanding of how atherosclerosis develops and new therapies for preventing heart attack and stroke.